Lagrangian computational modeling for biomedical data science

The goal of the project is to develop a new mathematical and computational
modeling framework for from biomedical data extracted from biomedical
experiments such as voltages, spectra (e.g. mass, magnetic resonance,
impedance, optical absorption, …), microscopy or radiology images, gene
expression, and many others. Scientists who are looking to understand
relationships between different molecular and cellular measurements are often
faced with questions involving deciphering differences between different cell or
organ measurements. Current approaches (e.g. feature engineering and
classification, end-to-end neural networks) are often viewed as “black boxes,”
given their lack of connection to any biological mechanistic effects. The approach
we propose builds from the “ground up” an entirely new modeling framework
build based on recently developed invertible transformation. As such, it allows for
any machine learning model to be represented in original data space, allowing for
not only increased accuracy in prediction, but also direct visualization and
interpretation. Preliminary data including drug screening, modeling morphological
changes in cancer, cardiac image reconstruction, modeling subcellular
organization, and others are discussed.

Public health relevance
Mathematical data analysis algorithms have enabled great advances in technology for building predictive models from biological data which have been useful for learning about cells and organs, as well as for stratifying patient subgroups in different diseases, and other applications. Given their lack to fundamental biophysics properties, the modeling approaches in current existence (e.g. numerical feature engineering, artificial neural networks) have significant short-comings when applied to biological data analysis problems. The project describes a new mathematical data analysis approach, rooted on transport and related phenomena, which is aimed at greatly enhance our ability to extract meaning from diverse biomedical datasets, while augmenting the accuracy of predictions.